A Delphi Study of Implementation Strategies for Cervical Cancer Control Policies in Africa

Project Summary/Abstract
Cervical cancer burden falls heavily on women in low- and middle-income countries (LMICs). Cancer control
policies have the potential to address this burden by enhancing the reach of evidence-based primary, secondary
and tertiary clinical services, and the fidelity with which they are delivered—however, these policies must be
implemented if they are to achieve population health improvements. However, we lack a robust, empirically-
grounded, theoretically-driven understanding of the determinants of policy implementation success, nor of
strategies that could improve policy implementation.
This project engages a network of experts from African LMICs and global agencies through: (A) a three-round
Delphi process to identify determinants of policy implementation success in LMICs, beginning with the CFIR
(version 2 plus modifications for LMICs); (B) qualitative interviews, leveraging the CFIR and Bullock et al.’s policy
implementation framework, to understand the process and mechanisms by which these determinants operate;
and (C) another three-round Delphi process to identify strategies, from a subset of those in the ERIC
compendium, that could be used to strengthen cervical cancer policy implementation in African LMICs. This
study focuses on cervical cancer policy, but has relevance for other cancer policies and other public health
policies more broadly. The findings of this research can equip researchers and policymakers with empirically-
informed, expert-selected strategies that could be implemented and evaluated.
To our knowledge, this is the first study to systematically engage global experts in a theory-based, rigorous
process to identify both determinants of policy implementation success and strategies to address these
determinants. The project will leverage expertise of the MPIs in global cancer control and policy-focused
implementation science, a Scientific Advisory Board that includes implementation science experts and global
cancer control experts, and an Expert Panel of ~60 policymakers and other experts from African LMICs.
There has been much emphasis on crafting and introducing cancer control policies and plans in countries around
the world. We need to improve our understanding of how these are being implemented, and how this
implementation could be improved so that greater population health improvements can be achieved. This
research will generate the necessary building blocks—grounded in D&I science and modified for the LMIC
context through rigorous expert engagement processes—to strengthen policy implementation, and ultimately
work toward cervical cancer elimination globally.

Public health relevance
Project Narrative Approximately 90% of cervical cancer cases and deaths occur in low- and middle-income countries, and policies in these countries have enormous potential to reduce this burden by improving the reach and fidelity of evidence- based clinical services for the primary, secondary and tertiary prevention of cervical cancer—but we know little about how to evaluate or strengthen the implementation of such polices. This study will engage a global network of policymakers and other experts in two Delphi processes (each with three rounds) and qualitative interviews, all leveraging implementation science theories and tools, to (1) identify determinants of cervical cancer policy implementation in low- and middle-income countries, (2) understand the processes and mechanisms by which these operate, and (3) identify candidate strategies for strengthening cervical cancer policy implementation.